The impact of early life stress on the immature primate amygdala: influence on mental health trajectories

In primates, the amygdala has a central role in learning and responding appropriately to social
behaviors. Difficulty in social function is a feature of many psychiatric disorders, and early social difficulties
may be a harbinger of disease onset. In both humans and monkeys, the amygdala matures in parallel with
evolving social repertoires during a protracted period from infancy through young adulthood. Surprisingly,
almost nothing is known of cellular changes underlying amygdala growth, or correlates with developing social
behaviors. This proposal focuses on a unique group of immature neurons found in the postnatal primate
amygdala (including human), and their potential for shaping social behavior over development. Importantly,
these immature neurons do not exist in rodents. Along with several other groups, we have characterized
immature neurons in the primate amygdala, and recently found that they are poised to mature to glutamatergic
projection neurons. This finding is buttressed by recent post-mortem human data showing that mature neurons
are added to specific amygdala nuclei in neurotypical children. We hypothesize that the path from immature to
mature neurons in specific amygdala regions is interrupted by early life stress, and correlates with the
development of atypical social behavioral outcomes.
Early life adversity in the form of maternal deprivation potently alters social behavior and amygdala
function in children and monkeys. We hypothesized that maternal deprivation would alter immature neuron
growth trajectories, and recently used microarray analyses to specifically explore the immature neuron cells.
We found strong, specific downregulation of genes governing neuroblast differentiation and migration in
deprived infants, suggesting maturational disruption by early life events. We also found a correlation between
the most strongly affected gene transcript (tbr1), and time spent in typical social behavior across all animals.
To begin interpreting these genetic changes, we began to investigate cellular data from the same cohort (fixed
hemisphere). Preliminary data suggest a reduced ratio of mature: immature neurons in maternally deprived
infants, raising the possibility of slowed or reduced growth of immature neurons. In this proposal, we use
archived tissue from two cohorts (infant and adolescent) to more fully explore: 1) cellular changes in immature
neurons during transition from infancy to adolescence, 2) how early life stress impacts this trajectory, and 3)
associated behavioral consequences. Aim 1: What is the normal trajectory of change in mature-to-immature
neuron ratios between infancy and adolescence in normal control nonhuman primates? What cellular features
(e.g. cell size, dendritic arborization, protein expression) track this? Does maternal deprivation alter this
trajectory? Aim 2: Across all animals in each cohort (infant and adolescent), what neural maturation measures
track duration (time spent) in typical social behaviors? Which behavioral developmental trajectories in each
cohort are most correlated with typical neural maturation? With atypical neural maturation?

Public health relevance
PROJECT NARRATIVE Primates, including humans, depend on complex social interactions for survival. Social repertoires begin in infancy, depend on caregivers, and involve the amygdala. This proposal explores a unique way that amygdala growth occurs in young primates, and how caregiver presence influences this growth, and developing social function.